Exhaustion mechanisms in Merkel cell polyomavirus-specific T cells

Abstract: Exhaustion mechanisms in Merkel cell polyomavirus-specific T cells
Merkel cell carcinoma (MCC) is a rare and deadly cancer that is rapidly rising in incidence. Approximately
80% of MCC cases are caused by the Merkel cell polyomavirus (MCPyV) with the remaining 20% of cases
caused by UV mutations. Immunotherapies targeting the PD-1 pathway have been highly successful in
patients with MCC. Anti-PD-1 therapy works by reinvigorating T cells which have entered a dysfunctional state
known as exhaustion. However, these therapies are still insufficient for long-term disease control in half of
patients with advanced MCC and must be further studied. In most other cancers T cells recognize unique
tumor mutations that vary from patient to patient. Because T cell targets are unique for each patient, studies of
cancer-specific T cells are largely infeasible in mutationally driven cancers. However, in the case of virus-
positive MCC, T cells recognize viral proteins driving the cancer which are shared across patients. Over the
past decade our lab has developed tools to study T cells that recognize these viral oncoproteins. These tools
put us in a unique position to study cancer-specific T cells from our extensive repository of more than 1,500
MCC patients. These reagents will be key to understanding why some patients do or do not respond to anti-
PD-1 therapy in MCC as well as in other cancers where studies of tumor-specific cells would be infeasible.
Aim 1 of this proposal will use newly developed techniques to extensively characterize circulating cancer-
specific T cells in MCC patients over the course of anti-PD-1 therapy. Specifically, high dimensional flow
cytometry, single cell RNA sequencing and T cell receptor sequencing will be used to characterize clonal,
MCPyV-specific T cells over the course of anti-PD-1 therapy. T cells from patients that respond or do not
respond to therapy will be compared to identify deficiencies in the T cell response which could be augmented
in future clinical trials. Aim 2 will study a putative state of dysfunction that we identified in MCC-specific CD4
helper T cells. CD4 T cells are highly understudied but are known to be important for control of chronic
infections and cancers. This aim will investigate the cytokine secretion profile and cytotoxic capacities of these
cells to determine if they exert an immune suppressive phenotype. We hypothesize this dysfunction could be
helping cancers evade the immune response and believe these studies could inform future clinical trials.
This project is ideal for training young physician scientists due the highly translational nature of the
research, the extensive background of Dr. Paul Nghiem in training previous MD-PhD students, and the quality
research and medical education at the University of Washington. The activities detailed in this proposal will
provide a strong background for a future career as a physician scientist.

Public health relevance
Narrative Merkel cell carcinoma is a rare but aggressive skin cancer that is highly responsive to immune therapy with roughly half of patients achieving long term benefit. Most cases of Merkel cell carcinoma are caused by the Merkel cell polyomavirus which allows us to identify cancer specific T cells across many patients by identifying cells that recognize this virus. This proposal will study these cancer specific T cells and what characteristics of these cells predict response to immune therapy.